Physics and Biology in Medicine Research Training

Abstract:
The specific aim of the resubmission of this training grant's competitive renewal proposal is to continue the
development of research scientists that are well versed in physics, biology, mathematics, chemistry, engineering
and computer science, who also understand the application of these disciplines to the detection, diagnosis and
assessment of treatment of disease. While the focus of this training program is the UCLA Physics and Biology
in Medicine Interdepartmental Graduate Program, the training program is not limited to the traditional practice of
Medical Physics and is much broader in scope. This training program has four tracks. The Medical Imaging
track investigates the physics of diagnostic radiology modalities (e.g. MRI, MR Spectroscopy, CT) and Computer
Vision methods to investigate areas such as quantitative imaging, imaging biomarkers, Radiomics and many
Machine Learning/Deep Learning approaches (detection and diagnosis of disease) all of which seek to extract
additional information from image data and relate it to other key information about patients and disease. The
Molecular Imaging track investigates a wide range of topics including the physics of PET, optical and combined
imaging modalities, microfluidics, theranostics, development of personalized dosimetry for radionuclide therapy
and others, all of which focus on providing investigations of basic biological mechanisms, both normal and
pathological using Molecular Imaging technologies and processes. This includes investigations with applications
in oncology (including responses to immunotherapies), traumatic brain injury, neurodegeneration and other
conditions. The Molecular and Cellular Oncology track investigates the molecular, cellular, and tissue-related
effects of radiation. This also includes a wide range of topics from investigating normal tissue responses to
radiation and mitigation of radiation effects on such tissues, tumor biology with special reference to cancer stem
cells, imaging cancer stem cells and responses to radiation therapy, combining radiation and immunotherapy
approaches and others. The Therapeutic Medical Physics track investigates novel approaches to treatment
delivery systems including methods to improve the accuracy of treatment delivery such as breathing motion
models for real time MRI guided treatment delivery to 4π treatment methods, real time MRI imaging and therapy
(using the ViewRay system) and brachytherapy techniques. This program has been training primarily Ph.D.
students for more than 60 years, and is unique in that it brings together researchers from basic sciences with
investigators in the clinical translational sciences and physicians who are truly clinical researchers, all in a
common environment dedicated to bringing basic research to clinical applications. This program has the faculty,
students, infrastructure and backing of its supporting Departments (Molecular and Medical Pharmacology,
Radiological Sciences and Radiation Oncology) as well as the Graduate Programs in Biosciences to continue to
achieve its goals of training the next generation of interdisciplinary scientists.

Public health relevance
Project Narrative: This training grant aims to continue to develop research scientists that are well versed in physics, biology, mathematics, chemistry, engineering and computer science, and who also understand the application of these disciplines to the instruments and techniques used in the diagnosis, monitoring and treatment of disease as well as research fields that help us understand basic mechanisms of disease. These scientists will become actively involved in research into new methods that seek earlier diagnosis of disease as well as more specific (patient specific, disease specific) treatments of disease in many clinical applications.